The role of proBDNF-p75NTR signaling in hind limb ischemia.

The role of proBDNF-p75NTR signaling in hind limb ischemia
Brain-derived neurotrophic factor (BDNF) and its precursor proBDNF have been well characterized in
their contrasting roles in neuroprotection and neuroinflammation in the central nervous system respectively.
Recently, BDNF and proBDNF have been shown to exist in tissues outside of the central nervous system, but
their role in these tissues is still unclear. In my study it was shown that whole muscle lysate contains high
levels of proBDNF and relatively low levels of mature BDNF compared to whole brain lysate. This project aims
to investigate the functional role of skeletal muscle-derived proBDNF in hind limb ischemia-reperfusion (IR)
injury. In this model, in which C57BL/6 mice are subjected to ligation of the right hind limb, proBDNF and its
receptor p75NTR were both upregulated, and p75NTR downstream signaling pathways were activated in the
ischemic muscle compared to the contralateral control limb muscles. The data further showed that treatment
with LM11A-31, a p75NTR moderator, following IR injury improved perfusion of the ischemic limb compared to
untreated IR controls, indicating improved endothelial function. Moreover, skeletal muscle-specific knockout of
BDNF significantly improved the blood perfusion in the ischemic limb compared to wild-type mice. Previous
studies have suggested that endothelial p75NTR may mediate vascular injury. Based on these results, we
hypothesize that the upregulated proBDNF in skeletal muscle following IR injury may stimulate endothelial
p75NTR, promoting cleavage of the intercellular domain (ICD) and subsequent inhibition of PKA-induced
phosphorylation of eNOS and nitric oxide production leading to vascular dysfunction and inflammation. To test
this hypothesis, mice with skeletal muscle-specific knockout of BDNF will be used to determine the role of
muscle-derived proBDNF in IR injury. Then mice with endothelial-specific knockout of p75NTR will be used to
examine whether endothelial p75NTR mediates IR injury. Finally, in vitro and in vivo experiments will be used
to define the inhibition of PKA by the ICD of p75NTR and subsequent eNOS function being responsible for the
IR injury. The results of this project will reveal a novel mechanism underlying IR injury and suggest new targets
for the prevention and treatment of IR injury in patients. While under the superior intellectual guidance and
support of a mentor with over 20 years of experience in the field, functional knowledge of experimental design,
data analysis and interpretation, and scientific communication will be developed, leading to Ph.D. and enabling
a successful and productive career in biomedical research. Experiments will be carried out using top-of-the-line
research equipment in premier facilities with ample opportunities for learning, growth, and support.

Public health relevance
Project Narrative The roles of brain derived neurotrophic factor (BDNF) and its precursor proBDNF in the central nervous system have been shown to play major roles in health and disease, however, their roles in skeletal muscle tissues have yet to be determined. The proposed work aims to investigate the role of skeletal muscle-derived proBDNF on its receptor p75NTR in the endothelial cells of the microvasculature in skeletal muscle in ischemia-reperfusion injury. Determining the role of the proBDNF-p75NTR signaling pathway will lead to therapeutic targets to help treat and prevent ischemia-reperfusion injuries in patients.